Sympathetic nervous system mediation of acute exercise effects on childhood brain and cognition

Project Summary/Abstract
Despite widespread public health campaigns, children have become increasingly inactive, leading to public
health concerns for children of industrialized nations. In addition to physical health issues (e.g., the recent
obesity pandemic), physical inactivity has been related to decreased cognitive and academic performance,
with a wealth of literature indicating that physical activity is positively related to brain and cognition. The
significance of this proposal lies in uncovering a biomarker that links the beneficial effects of a single bout of
aerobic exercise to childhood brain, cognition, and academic achievement. To date, no such explanatory
mechanism has been demonstrated in the literature. Given the importance of physical activity to brain health
and cognition, we propose to investigate phasic shifts in sympathetic nervous system (SNS) activity using the
biomarker salivary alpha-amylase (sAA), as a potential mechanism mediating the beneficial effect of a single
bout of exercise on brain, cognition, and achievement in children using a randomized crossover design. sAA is
phasically increased during physical and psychosocial stress as part of the first wave of the `fight or flight'
response. Stress-induced modulation of sAA has been related to alterations in prefrontally-mediated executive
control functions (i.e., inhibition, working memory, cognitive flexibility) and academic achievement in children.
This proposal aims to study phasic shifts in sAA following a bout of aerobic exercise, and relate such changes
to measures of brain function (i.e., the P3 component of an event-related brain potential), executive control,
and performance on standardized achievement tests of reading and arithmetic. In this regard, the proposed
research will be the among the first to investigate the molecular underpinnings of the acute exercise-induced
changes in cognition and brain in children through a combination of molecular, neuroimaging, behavioral, and
academic achievement measures. Through the collection of salivary, neuroimaging, and behavioral outcomes
in the proposed randomized crossover experiments, we can begin to establish the multidimensional nature of
the transient effects of a single bout of exercise on the underlying molecular and neural changes that promote
cognitive health and academic achievement during childhood. Findings consistent with our general hypothesis,
that the SNS mediates exercise effects on brain, cognition, and achievement, has considerable implications for
understanding factors that lead to maximizing physical health, neurocognitive function, and the educational
experience. Such empirical support stands to benefit educational practices and current methods of learning,
and provides the necessary `hard evidence' to promote the adoption of exercise during the school day to
improve the cognitive health and scholastic performance of a broad range of children. Accordingly, the
proposed research is not only aimed at determining a mechanism underlying the effects of a single bout of
exercise on cognitive and brain health, but also at curbing the public health issue of inactivity that is decreasing
the health, wellness, and academic potential of our nation's children.

Public health relevance
Relevance Recent international trends have identified decreasing levels of physical activity and health in preadolescent children. Examining physical activity behaviors that positively influence brain health, cognition, and academic performance of preadolescent children are important for improving school performance, maximizing overall health, and improving the function of individuals as they progress through the human lifespan. In our proposed research we will examine, for the first time, a biological mechanism that may mediate the beneficial effect of a single bout of exercise on brain function, cognition, and academic achievement of preadolescent children.